Lipoprotein and HDL Function Core

Summary
Anti-atherogenic functions of HDL are likely due to its mediation of reverse cholesterol transport
and to its anti-oxidative and anti-inflammatory effects. Mounting evidence supports the concept
that HDL may become dysfunctional and that this contributes to the development of
atherosclerosis. The goal of our research is to define the mechanisms for HDL dysfunction in
diseases associated with significantly increased risk of atherosclerotic cardiovascular disease,
including familial hypercholesterolemia, chronic kidney disease and rheumatoid arthritis. A major
hypothesis of our proposal is that excessive inflammatory and oxidative burden impair HDL
atheroprotective functions, including cholesterol efflux capacity and anti-inflammatory and anti-
oxidative effects. Core B will be an integral part of the PPG by providing both analytical services
for analysis and isolation of lipoproteins and in vitro assays of HDL function in macrophages. The
goal of Specific Aim 1 is to provide isolation and analysis of lipoproteins, HDL subfractions, and
apoproteins. The Lipoprotein and HDL Function Core (Core B) will assist investigators by isolating
lipoproteins and apoproteins, including apoAI and apoAII, for functional studies and analyses of
protein modifications. The goal of Specific Aim 2 is to provide assays for HDL functions, including
the promotion of cholesterol efflux and efferocytosis in macrophages and the control of
inflammation and oxidation. Core B provides a number of services to investigators that require
unique instrumentation and methodologies and demand rigorous standardization procedures. It
would be costly, inefficient, and cumbersome to establish these procedures in individual
investigator laboratories. The consolidation of these services into the Core B laboratory provides
investigators with efficient, high quality, low-cost analyses. Another objective of Core B is to
provide education and training to investigators, fellows, and research technicians on the science
and methods of lipoprotein preparation and studies of HDL function.